Community Interactions Outreach - Neuron and Glial Cellular Signatures from Normal and Diseased iPS Cells

Community Interactions & Outreach Component The NeuroLINCS Community project will plan to provide resources and tools for a broad user base of basic and clinical scientists. It has a structure to facilitate access to the various genetic and proteomic data sets, the signatures created, and the analysis tools. It is designed to be directed to researchers at the bench, clinicians developing biological disease readouts and those in computational roles. It will incorporate an assessment to demonstrate the utility of the generated resources, methodologies, and analytical tools to LINCS and non-LINCS scientific community. Importantly, it will develop and implement a plan to bring in external collaborators who may have data sets that bear on the development of cell signatures. There is an extensive plan to develop workshops, tutorials, and symposia in conjunction with the use of innovative online technologies for disseminating information to target the major LINCS goals. Finally it will develop bidirectional links with the neuroscience clinical and basic community through a series of collaborations with large National clinical data and tissue-based networks.

Public health relevance
The proposal will bring a highly experienced team of investigators committed to understanding the basis of neurological disease, to study stem cells derived from adults or children with devastating progressive neurological diseases such as Lou Gehrig's disease, Huntington's disease and spinal muscular atrophy. Using the leading technologies, computer analytics and tools these special cells will be studied to understand why disease occurs and identify changes where drugs might be useful. Overall this could serve as a critical foundation and pathway towards new disease therapies.